Predoctoral Training in Genetics and Molecular Biology

The Genetics and Molecular Biology (GMB) Training Program at Princeton University educates carefully
selected individuals for the research, teaching, and advocacy needs of the nation. The GMB Training
Program brings together the multi-disciplinary life science community at Princeton, which has a 57-member
training faculty who are currently mentoring 126 graduate students, 103 postdoctoral fellows, and 109
undergraduate majors. Our program is highly collaborative and we train our students with the skills to
become leaders in any field they choose. The 36 training faculty from the Department of Molecular Biology
include 6 with joint appointments in the Lewis Sigler Institute for Integrative Genomics (LSI) and 5 with joint
appointments in the Princeton Neuroscience Institute (PNI). The GMB training program also includes 5
faculty from Chemistry, 6 from Chemical & Biological Engineering, 3 from Ecology & Evolutionary Biology, 2
from Computer Science, 2 from Physics, 1 from Mechanical & Aerospace Engineering and 2 Institute
professors (1 from LSI and 1 from PNI). The faculty provides expertise in diverse biological systems and
offers training in genetics, genomics, biochemistry, biophysics, structural biology, cancer, cell biology,
development, microbiology, immunology, and neuroscience. All of the faculty focus on model systems
appropriate for training on a Genetics and Molecular Biology training grant. We receive approximately 350
applications to our graduate program per year and we attract some of the best students in the country.
Research is performed in well-equipped laboratories with support from state-of-the-art core facilities. The
training program consists of formal course work, laboratory rotations, a general exam, thesis research,
thesis committee meetings, Individual Development Plans, and an array of special activities that enhance
the formal education and provide our students with expert speaking and writing skills and exposure to the
full breadth of career possibilities. In addition, trainees gain teaching experience and receive broad training
in responsible conduct of research. We have developed a Diversity Program that is highly successful in
identifying and recruiting students from groups that are under-represented in the life sciences. Indeed, our
gender and racial demographics match that of the nation and we have sustained those demographics for
nearly a decade. As part of our Mentorship Program, we have developed activities that benefit all students.
Routine evaluation of the GMB Training Program involves both faculty and students and enables us to
identify needs for new courses, policies, and activities that keep the program fresh. Its success is best
judged by the productivity and success of our graduates, more than 90% of whom are actively engaged in
science-related careers. Our GMB program thus nucleates the vibrant multi-disciplinary research
community at Princeton and delivers scientists who have been broadly trained and provided with the
interdisciplinary perspective and cross-disciplinary skills they need to solve tomorrow's problems.

Public health relevance
The Genetics and Molecular Biology Training Program at Princeton University is a diverse and inclusive program that trains graduate students to become leaders in biomedical research, teaching, and related life science fields. We use a multi-disciplinary research, educational, and mentoring program that emphasizes advanced skills like critical thinking, writing, and oral presentation. Research projects directed by program faculty train Ph.D. candidates in diverse areas related to human health including reproduction and development, infectious disease, cancer, and aging.